Quantitative assessment of glaucomatous conventional outflow dynamics

Project Summary
Intraocular pressure (IOP) control is a dynamic process that is regulated by the conventional outflow tissues;
effectively maintaining intraocular pressure within a couple of millimeters of mercury in most people over a
lifetime. In some, however, defects in conventional outflow function result in ocular hypertension, a primary risk
factor for damage to retinal ganglion cell axons and the development of glaucoma. Until now, our understanding
of conventional outflow tissue dynamics has relied on indirect measurements or fixed/processed tissues,
capturing only snapshots of information. Hence, visualization and quantification of outflow dynamics in vivo has
not been possible.
For the present study, we have developed novel perfusion methods and Optical Coherence Tomography (OCT)
instrumentation, techniques, and image processing procedures that enable direct visualization, integration, and
quantification of conventional outflow dynamics over time in living mice (an established model of conventional
outflow anatomy, physiology, and pharmacology). Armed with such technology, we can specifically tackle
longstanding questions about conventional outflow (dys)function in aging and glaucoma. The current proposal
is guided by the hypothesis that the dynamic and integrated conventional outflow function diminishes with age
and disease; these are changes that can be reversed by drug treatment and are quantifiable. To address this
hypothesis, we have designed three specific aims to (i) Examine conventional outflow tissue behavior in adult
and elderly mice challenged with IOP elevations or conventional outflow drugs; (ii) Monitor changes in
conventional outflow tissue behavior in two established mouse models of ocular hypertension (corticosteroid-
induced and caveolin-1 knockout); (iii) Optimize newly developed OCT hardware, software, and perfusion
techniques for better evaluation of the conventional outflow pathway.
Knowledge gained from these fundamental experiments in a pliable model will be used toward our ultimate goal
of improving glaucoma management in humans, including: early diagnosis, detecting minor changes in outflow
function; monitoring response to medical treatment, enabling personalization of treatment; mapping of flow
patterns to enable effective placement of shunts; and subtyping of glaucoma disease.

Public health relevance
Project Narrative Glaucoma is the second leading cause of blindness worldwide and the leading cause among African- Americans. Clinical trials have definitively shown that effective lowering of intraocular pressure is neuroprotective; preserving vision regardless of intraocular pressure status at time of glaucoma diagnosis. The goals of the present proposal are to develop novel technologies to objectively assess and monitor the tissue that regulates intraocular pressure, with age, in different disease subtypes and in response to different therapies; which is the first step in a continuum of research leading to early and accurate diagnosis of, and effective personalized therapy for glaucoma.